Admin Core

ABSTRACT, ADMINISTRATIVE CORE
The Administrative Core will be the central hub of the B-HIVE Center and jointly directed by Stefan Sarafianos
and Bruce Torbett. The Administrative Core will help to ensure that the Center achieves its full scientific potential
by fostering a Center-wide collaborative and expansive environment that will make it greater than the sum of its
parts. Our mission will be actualized through collaborative leadership. The goal for achieving a successful Center
will rely on our collaborative leadership and support to ensure investigator connectivity and cohesiveness, a
shared and committed scientific vision amongst Center Investigators, and strategic planning. Throughout all of
our proposed scientific activities, we will focus on training the next generation of HIV scientists and engaging
beyond our Center’s investigators to recruit, develop, and retain a truly diverse B-HIVE research community. To
accomplish the goals of the Administrative Core to support the Center to be greater than the sum of its parts and
to remain at the forefront of structural and functional virology, we proposed the following Aims:
Aim 1. Leadership and Communication: Promote engagement and scientific collaboration across the Center
through effective leadership and clear communication.
Aim 2. Fiscal and Regulatory: Provide comprehensive fiscal management and timely reporting to Center
members, Center Developmental Program funded recipients, member and home institutions and the NIH, as
well assemble and complete yearly non-competitive NIH renewals and SAB reports.
Aim 3. Strategic Planning: Enhance the quality of scientific progress, technological advancements, training, and
implementing Equity, Diversity, and Inclusion (EDI).
Aim 4. Inclusion of NIH Intramural Researchers in the B-HIVE Center.